TREATMENT OF ORTHOSTATIC TACHYCARDIA

Test the relationship of hypovolemia to the severity of orthostatic tachycardia and that interventions that perturb volume or autonomic function will improve the hemodynamic profile in these patients. We are beginning recruitment and screening.